Structural and Functional Studies of Cell-Adhesion Receptors

Project Summary from Parent Award
Cellular communication is essential for the development of all multicellular organisms, and is a key phenomenon
that is disrupted in many human diseases. Cell-surface receptors mediate cellular communication and are the
targets for 50% of FDA-approved drugs, highlighting their disease relevance and druggability. However, many
cell-surface receptors remain understudied and undrugged. The research proposed in this application is focused
on two families of such receptors, adhesion G Protein-Coupled Receptors (aGPCRs), and teneurins. The
structures, mechanisms of action and disease relevance of these two receptor families remain largely unknown;
as their large size and complex biochemical nature has made them difficult to study. Recent genetic studies
revealed that aGPCRs and teneurins have essential roles in development of the nervous system, skeletal
system, and heart. These receptors are linked to diseases including cancer, developmental disorders, and brain
malformations, raising an urgent need for mechanistic studies on aGPCRs and teneurins. My research program
aims to elucidate the molecular mechanisms by which these receptors are activated, and to develop new tools
to modulate their activity against relevant diseases. The research proposed in this application involves an
interdisciplinary approach, integrating structural studies of these receptors and their ligands, biochemical and
biophysical assays, protein engineering approaches, and functional assays. This research will build on our
previous successes using this approach, which has yielded many three-dimensional structures of aGPCRs and
teneurins, has revealed crucial mechanistic concepts in the field, and has allowed a better understanding of the
mechanisms of action of these receptors. A major revelation from our work is that the large extracellular regions
of aGPCRs and teneurins are directly involved in regulating receptor function. Despite these advances,
fundamental questions remain unanswered. The ultimate goals of this proposal are to reveal how signal
transduction is mediated within the domains of these large receptors, what exactly activates them under
physiological conditions, how their evolution from early organisms to higher eukaryotes have changed and
diversified their critical functions, and finally how, at the molecular level, we can inhibit or activate these receptors
using synthetic ligands. Our structural studies will be complemented with mutagenesis, signaling assays, the use
of synthetic binders to understand how the different components of these receptors control receptor function,
and physiological analyses performed by collaborators that will test the relevance of the structural and functional
studies. We expect that this research will provide critical insights into the mechanistic details of aGPCR and
teneurin function that will be highly informative for the development of future therapeutics; we will also produce
potent and selective synthetic ligands which can serve as tools for the scientific community to study aGPCRs
and teneurins.

Public health relevance
Project Narrative from Parent Award Cell-adhesion receptors are key molecules for cellular communication and have emerging functions in numerous cellular processes. The research proposed in this application will yield key insights into fundamental molecular mechanisms that underlie the function of two poorly understood families of cell-adhesion receptors in multicellular organisms (namely the 33 adhesion G Protein-Coupled Receptors (aGPCRs) and the four teneurins). This research will provide critical knowledge into the molecular mechanisms of intercellular communication, and since many aGPCRs and teneurins are found mutated in neurological disorders and cancers, this research is expected to provide crucial clues for the development of novel strategies to understand and treat these disorders.